Using Multi-Omics to Define Regulators and Drivers of Granulomatous Inflammation and Chronic Beryllium Disease

PROJECT SUMMARY/ABSTRACT:
The goal of this study is to define cell-specific regulatory networks and key drivers of cellular response to beryllium
(Be) that result in the granulomatous lung disease, chronic beryllium disease (CBD), at the site of organ
involvement. Relying on the complementary, unique expertise of investigative team we will define pathogenic
pathways and risk factors for CBD, its precursor (Be sensitization; BeS) and similar environmentally induced
diseases. Exposure to an inhaled Be antigen(s), in the setting of a genetically susceptible host, initiates a Th1
immune response, with antigen presentation occurring via HLA Class II on antigen presenting cell (APC) in the
context of CD4+ T cells. Subsequently, CD4+ T cells and APCs are recruited to the lung, proliferate, produce
cytokines and chemokines, and eventually form granulomas. An increased prevalence of HLA-DPB1 alleles with
a glutamic acid at amino acid position 69 (E69) is found in CBD and BeS, although this variant is found in up to
40% of Be exposed workers without BeS or CBD, suggesting that other factors or forms of genetic regulation are
important in disease pathogenesis. Growing data in other immune-mediated diseases suggests that epigenetic
mechanisms in combination with genetic susceptibility and environment may help explain disease risk. Epigenetic
modifications determine T cell and APC/macrophage differentiation and the ensuing immune response through
DNA methylation and histone modifications of key genes and thus impact health and disease. Our previous work
demonstrated DNA methylation changes associated with alterations in gene expression and disease state in
bronchoalveolar lavage (BAL) cells of CBD subjects compared to BeS and controls, including pivotal immune
response genes and networks. Single cell sequencing technologies have emerged as a key method to
characterize novel cell population and cell-specific changes in gene expression. Based on this information, our
hypothesis is that exposure to Be alters epigenetic marks, impacting gene expression and immune cell
differentiation in cell-specific manner, and ultimately risk of granulomatous lung disease. We will test this
hypothesis through three specific aims, focusing mainly on macrophages and CD4+ T cells but acknowledging
that other cell populations are important and considering them in alternative approaches and future directions. In
Aim 1 we will characterize the lung immune cell response to Be exposure using single cell ATAC-seq and CITE-
seq to measure chromatin accessibility, gene expression levels and protein epitopes at four timepoints to define
key drivers in specific cell populations. In Aim 2 we will validate the regulatory networks in uncultured lung
samples, focusing on macrophages and CD4+ Tcells, using bulk ATAC- Me and RNA-sequencing. We will
functionally validate the results from our multi-omic analysis from Aims 1 and 2 using CRSIPR-dCas9 to change
methylation, chromatin accessibility, and gene expression at loci identified as key drivers of response to Be in
cultured macrophage and T cell lines in Aim 3. Ultimately, this proposal will enhance our understanding of the
novel genes, regulatory pathways and networks, and molecular mechanisms involved in CBD etiology.

Public health relevance
PROJECT NARRATIVE The reason why some develop exposure related diseases, such as the scarring lung disease chronic beryllium disease, while others do not is not well understood. This proposal may help explain why some people get CBD, while also defining drivers and new genes important in the development of this and other similar diseases, as well as helping us understand how beryllium exposure may change these drivers and genes. In future studies, these factors may serve as biomarkers or predictors of disease and ultimately even targets for therapy.